RISE: Enhancing Biomedical Achievement in Science and Engineering (RISE-E-BASE)

PROJECT SUMMARY
The University of Puerto Rico at Mayaguez (UPRM) submits the proposal entitled RISE: Enhancing Biomedical
Achievements in Science and Engineering (RISE: E-BASE). The proposal will support research and educational and
training activities of 32 students distributed as 20 undergraduates, and 12 PhD students pursuing biomedical sciences
and biomedical engineering research. The longterm goal of this proposal is to increase the number of Hispanic
minorities that pursues and completes PhD degrees in biomedical sciences and biomedical engineering with adequate
preparation in the responsible conduct of research in addition to technical and professional skills. The specific aims to
achieve this goal are : Specific Aim 1: Increase the number of underrepresented (UR) undergraduate (UG) students
that pursue doctoral studies in biomedical sciences and biomedical engineering, and, Specific Aim 2: Increase the number
of doctoral UR students that complete a PhD in biomedical sciences and biomedical engineering with competitive research
skills. These specific aims will be accomplished by engaging undergraduates and PhD students in meaningful research
experiences in biomedical sciences and biomedical engineering and through a series of workshops to develop and increase
the professional skills needed to pursue and complete a PhD degree in areas of interest of the National Institute of General
Medical Sciences (NIGMS). The program activities are designed to provide each student cohort (UG and PhD) with the
awareness, knowledge, and skills to continue to advanced education in biomedical sciences and biomedical engineering.
Emphasis will be given to the institutionalization of a research and career development curriculum through the creation of
new courses in biomedical sciences, experimental design, and training in new research technologies. The program
impact in the undergraduate curriculum will result in the modernization of one research introductory course work for
undergraduate students. The program impact in the graduate curriculum will result in the creation of new course work in
(1) modern technologies that will expose PhD students to state-of-the art technologies through seminars and workshops and
(2) experimental design to develop an evidence based research proposal that can be central to the dissertation work and will
be submitted for external funding to federal and non-federal agencies. The research activities will be supported at the
laboratories of 20 UPRM in-campus mentors and 17 off-campus mentors from science and engineering departments. The
37 research mentors have demonstrated grantsmanship, publication and dissemination record and will play a central role in
providing adequate guidance to fulfill the long term goal of the proposed plan. The student to faculty ratio close to 1:1 and
is ideal for a meaningful research experience and effective development of research skills in an interdisciplinary setting of
biomedical science and engineers. The participating RISE students will have the benefit to select from summer off-campus
research or COOP experiences. Research areas will include biomaterials, biomedical instrumentation, drug delivery,
bioinformatics, neuroscience, nanomedicine, molecular and cellular biology, population genetics , among others.
Workshops to (1) improve and motivate students to pursue and complete the PhD degree, (2) train in issues related to the
responsible conduct of research, (3) improve communications and research skills will also be offered.

Public health relevance
NARRATIVE The RISE-E-BASE program of the University of Puerto Rico at Mayagüez (UPRM) will support educational and research training activities of 20 undergraduate and 12 PhD students from science and engineering departments pursuing biomedical sciences or biomedical engineering research and training activities at the laboratories of 20 UPRM and 17 off-campus mentors in areas of interest to the NIH-NIGMS. Students will conduct research in biomaterials, biomedical instrumentation, drug delivery, bioinformatics, genetics, genomics, neuroscience, nanomedicine, and molecular and cellular biology, among other areas.